Health And Disease Status In The Blsa--Prostate Gland

The Baltimore Longitudinal Study of Aging (BLSA) prostate aging and disease study has both retrospective and prospective arms involving repeated assessments of anatomical, physiological, hormonal, and behavioral aspects of age-associated changes in prostate size. The retrospective arm of the study examines the sex steroid and PSA levels from frozen sera stored during the three most recent visits and visits closest to 10, 15, 20 and 25 years before study initiation. The prospective arm involves male BLSA participants and has continued for more than 10 years. Data collection has been on hold since December 2002, and hopefully will begin again in the coming months. Our previous work suggests that prostate cancer develops over a period of at least 10 years in most men, and that PSA can stratify men at risk as long as 20 to 30 years prior to diagnosis. Over the past year, we have continued to explore factors that contribute to prostate cancer and the impact of prostate health. Two studies examined risk factors for prostate cancer, one examined psa and prostate symptomatology, and one the association of psa and mortality. 1. Insuling, glucose and anthropometry: A major interest is to identify and understand the risks associated with prostate cancer. Differences in rates have been found based on geographical localization. Western lifestyles increase the risk of clinically relevant prostate cancer, as the incidence rate is low in Asia compared with the West. Asian immigrants to Western countries develop prostate cancers at greater rates. One factor implicated in this difference is related to dietary differences and resulting differences in obesity. We examined the relationship of insulin, glucose, and anthropometry with the subsequent risk of prostate cancer in men from the BLSA. Fasting insulin and glucose levels were unrelated to prostate cancer risk in our overall analysis. No risk was noted for body mass index or waist circumference, but the relative risk of prostate cancer for the second through fourth quartiles of the waist/hip ratio compared with the lowest quartile was 2.10, 1.96, and 2.06, though these ratios were not significant. The results of this study do not support positive associations of markers of insulin and glucose metabolism and obesity with prostate cancer. 2. NSAIDS: Laboratory and epidemiologic studies suggest that aspirin and non-aspirin non-steroidal anti-inflammatory drugs (NSAIDs) reduce the risk of cancer, possibly via inhibition of the cyclooxygenase enzymes. We evaluated the association of aspirin and non-aspirin NSAIDs with subsequent prostate cancer in BLSA men. We also assessed whether use of these drugs influences serum PSA concentration. The RRs of prostate cancer comparing ever to never use were 0.76 (95% CI 0.54-1.07) for aspirin, 0.79 (95% CI 0.54-1.16) for non-aspirin NSAIDs, and 0.71 (95% CI 0.49-1.02) for either medication. The association for ever use of either aspirin or non-aspirin NSAIDs was suggestively more pronounced in men < 70 years (RR=0.54, 95% CI 0.27-1.03) than in men ≥d 70 years (RR=0.78, 95% CI 0.50-1.22; p-interaction =0.73). The RR for current use of either drug was attenuated relative to ever use. Mean PSA concentration did not differ between users and non-users of either aspirin or non-aspirin NSAIDs (1.01 vs 0.98 ng/mL, p=0.56). The study suggests that men, particularly younger men, who had ever used aspirin or non-aspirin NSAIDs may have a modestly lower risk of prostate cancer. 3. Relationship of psa to lower urinary tract symptoms: Benign prostatic hyperplasia (BPH) is a common disease of aging men that can cause bothersome lower urinary tract symptoms (LUTS) affecting quality of life. There is growing interest in the identification of men who are more likely to have progression of BPH, in part because available medical therapy with alpha blockers and 5-#\ reductase inhibitors are now available for prevention of disease progression. PSA has been shown to be a reasonable surrogate for prostate volume with areas under the ROC curve ranging from 0.76 to 0.78 when PSA is used to predict prostate volumes cutoffs of 30, 40, and 50ml. Since PSA, as a surrogate of future prostate growth, is predictive of disease progression, and there is available medical therapy that can prevent prostate growth and disease progression, we evaluated the relationship between a baseline PSA and subsequent symptom progression over 3 decades among men who were not selected for the presence of LUTS in the Baltimore Longitudinal Study of Aging. We divided subjects into age groups of less than 50 years, and 50-69.9 years at the time of their first PSA evaluation. Subjects were divided into three PSA groups based on an initial PSA below the 25th percentile, 25th-75th percentile, and above the 75th percentile, and followed their symptom development using a questionnaire. There was no statistically significant difference in the symptom score distribution across PSA percentiles for men age less than 50 years (p=0.87) or age 50-69.9 years (p=0.59). These data suggest that PSA level is not a useful predictor of the development of lower urinary tract symptoms in unselected asymptomatic men. 4. PSA and mortality: Because PSA is a marker of two diseases, prostate cancer and benign prostatic hyperplasia, that are closely related to aging, we wondered if PSA levels might serve as a proxy for the aging process. Our hypothesis was that men in whom prostate disease is present might be biologically more advanced in age than those without prostate disease. If so, all-cause mortality, as a surrogate for aging, should be directly related to PSA. We demonstrated a statistically significant direct relationship between PSA and all-cause mortality, cancer mortality, and the development of cancer. For each ng/mL increase in PSA, there was a 3%!V5% increase in the risk of an event. There was no statistically significant relationship between PSA and cardiovascular mortality, and this finding was not due to the lack of events in the cardiovascular group since most deaths were from a cardiovascular event. The inclusion of body mass index, testosterone, and free testosterone index did not alter the observations. One possible explanation for our findings is that the development of prostate disease with age reflects a loss of growth-control mechanisms within the prostate that also occurs simultaneously in other tissues within the body. If so, men with prostate disease (and elevated PSA levels) would be at greater risk of non-prostatic neoplasia. Although we do not know why men with the highest PSA levels are at an increased risk of development and death from cancer other than prostate, the relationships between PSA and cancer mortality and between PSA and cancer development suggests that the events that lead to PSA elevations with age may be related to the development of cancer in non-prostate tissues. At this time, we are continuing to examine the role of dietary factors, body composition, and hormone levels on prostate diseases. We are completing work on examining the risk of prostate cancer in relationship to serum testosterone levels. In addition, we are starting to evaluate the relationship of urinary symptoms to prostate diagnoses. This includes examining how changing urinary symptom scores impact on quality of life, and the time course of change in urinary symptoms.